CHRONOBIOLOGY OF POSTPARTUM DEPRESSION

To determine if circadian rhythm disturbances, as measured by melatonin, contribute to the pathogenesis of postpartum depression and if these chronobiological disturbances can be treated by shifting the sleep-wake cycle and with phototherapy.